Stanford Neurosurgery and Neurology Resident Research Education Program

Project Summary / Abstract
The Stanford Neurosurgery and Neurology Resident Research Education Program
provides training in basic and clinical research, with the goal of fostering resident and
fellow growth into independent physician scientists. Through this education participants
are then capable of establishing and directing an independent scientific program and
obtaining individual research funding. We identify residents with the potential for and
commitment to scientific research, and place them for a one to two year term in the
laboratories of highly experienced and productive research scientists. Participants also
receive extensive counseling and participate in seminars on research skills and ethical
research behavior. Their progress and the success of the overall program is repeatedly
assessed, including obtaining individual research funding, and appropriate changes in
the program will be made. This program will produce neurosurgeons and neurologists
making new discoveries regarding the causes of diseases of the brain and spinal cord,
and enabling more effective treatments of these diseases.

Public health relevance
Project Narrative The Stanford Neurosurgery and Neurology Resident Research Education Program provides training in basic and clinical research, fostering resident and fellow growth into independent physician scientists. Stanford has a proven track record of training the next generation of physician scientists, as >70% of our neurosurgeons and neurologists graduate to academic practice and many obtain individual research funding. The continued support of the R25 will produce neurosurgeons and neurologists making crucial new discoveries regarding the pathophysiology and treatment of neurologic diseases.